Reactive Astrogliosis and the Tripartite Synapse in Alzheimer's Disease

PROJECT SUMMARY/ABSTRACT
Synaptic loss is considered the best correlate of cognitive decline in Alzheimer’s disease (AD) and has been largely
attributed to the toxicity of amyloid-β (Aβ) and phospho-tau (pTau) species, with microglia engulfing and
eliminating Aβ- and pTau-tagged vulnerable synapses. While astrocytes participate in the so-called “tripartite”
excitatory synapses, and reactive astrocytes surrounding Aβ plaques and pTau neurofibrillary tangles in the AD
brain are known to suffer dramatic morphological, functional, and molecular changes (collectively termed
reactive astrogliosis), the net effect of AD reactive astrogliosis on synaptic health remains a crucial gap of
knowledge. On one hand, reactive astrocytes may contribute to synaptic loss by secreting synaptotoxic factors
(e.g., C3, lipocalin-2) and suppressing the release of synaptogenic factors (e.g., thrombospondins). On the other
hand, a key feature of reactive astrocytes is the upregulation of the cytoskeletal intermediate filament glial
fibrillary acidic protein (GFAP), which has been implicated in the maintenance of the normal structure and
function of tripartite excitatory synapses (e.g., by trafficking glutamate transporters and potassium-buffering
channels to the astrocyte peripheral leaflets). Here we propose to investigate the role of GFAP upregulation by
reactive astrocytes in AD-related synaptic dysfunction and loss. Our central hypothesis is that the GFAP
upregulation associated with AD reactive astrogliosis is an adaptive compensatory response of astrocytes to
protect synapses in the setting of pTau-induced synaptic toxicity. Our overall goal in the present proposal is to
decipher whether and how tripartite synapses are altered by the GFAP upregulation characteristic of AD reactive
astrocytes. The rationale for this project is that, based on our preliminary data, GFAP upregulation by reactive
astrocytes may protect synapses from pTau toxicity; therefore, understanding this potentially compensatory
mechanism could hold therapeutic promise against AD-related cognitive decline. Our central hypothesis will be
tested by investigating whether and how astrocyte GFAP upregulation impacts tripartite excitatory synapses in
a tauopathy mouse model of AD, and whether and how blunting this astrocyte response impacts the proteome of
tripartite excitatory synapses in a tauopathy mouse model of AD. Specifically, we will overexpress GFAP in
astrocytes via viral gene delivery (aim 1) and blunt Gfap upregulation in reactive astrocytes with a mouse-specific
Gfap anti-sense oligonucleotide (ASO, aim 2) in AD tau transgenic mice and wild-type littermates. We will then
investigate changes in the protein composition and structure of tripartite synapses by performing tandem tag
mass (TMT)-based quantitative proteomics on synaptoneurosome preparations and array tomography on
ultrathin sections, respectively. Upon successful completion of these aims, our expected outcome is to have
delineated the changes in protein composition and structure of tripartite excitatory synapses downstream GFAP
upregulation and to have elucidated whether this feature of AD reactive astrogliosis is toxic, protective, or neutral
with respect to synapses.

Public health relevance
PROJECT NARRATIVE Astrocytes are structural part of the tripartite excitatory synapses and their cytoskeleton intermediate filament glial fibrillary acidic protein (GFAP) has been implicated in tripartite synapse integrity and function. Reactive astrocytes in Alzheimer’s disease (AD) upregulate GFAP but the consequences of these increased GFAP expression levels for tripartite synapse maintenance in the presence of synaptotoxic amyloid-β (Aβ) and phospho-tau (pTau) aggregates are unknown. Based on our preliminary data, here we will test the hypothesis that GFAP upregulation by AD reactive astrocytes protects synapses from the deleterious effects of pTau by both overexpressing and blunting this upregulation in a tauopathy mouse model of AD.